A longitudinal study of the outcomes, risk factors, and protective factors of dating violence and other adverse events

ABSTRACT
Each year, approximately 25% of US teens and emerging adults sustain physical, psychological, or sexual
abuse by dating partners. Many victims of dating violence (DV) experience a host of devastating
consequences, including acute and chronic mental and physical health problems, suicidality, delinquency, risky
sexual behavior, substance abuse, and academic/occupational failure. Moreover, perpetrators of teen DV are
at increased risk for continuing intimate partner violence in adulthood, and victims are at risk for future
victimization and perpetration. The vast majority of what we know about DV is derived from cross-sectional
studies, with a paucity of short-term longitudinal studies or long-term longitudinal studies where DV was a
secondary focus often assessed with single-item self-reported indicators. Moreover, existing long-term
longitudinal studies were conducted on older generations of adolescents. Given the changing landscape of
sexuality and intimate relationships, shifting norms in support of aggressive behaviors, and the advent of
electronic/social media, a contemporary long-term longitudinal study on DV is critically needed. To address
these questions and gaps in the literature, our research team (PI: Temple) completed an 8-wave/8-year
longitudinal study of DV in a large sample of 1,042 ethnically and socioeconomically diverse adolescents.
Participants were recruited and assessed as Freshman/Sophomore high school students (Mean age=15) in
2010, with follow-ups annually from 2011 through 2017 (from age 16 through age 22). We are proposing to
follow our current sample for an additional 5 years and add current partners of participants for the final 4 years.
When finished, we will have 13 years of rich DV data covering individuals from young adolescence through
young adulthood—during a period characterized by identity development and the beginning of dating to one
characterized by identity formation and the establishment of more permanent intimate relationships and life
trajectories. Specific aims are to examine 1) the longitudinal association of different forms of DV and their
association with later DV across multiple relationships; 2) the long-term impact of exposure to DV and other
adverse events on adult mental, physical, and psychosocial health; 3) dyadic influences on risk for, and
protection from, DV across time; and 4) differences in DV perpetration and victimization over time by sex, age,
sexual orientation, and race/ethnicity, and in the ability of risk and protective factors to concurrently and
prospectively predict DV and other adverse outcomes in each subgroup. This will be the longest study ever
conducted with a primary focus on DV, and provides an unprecedented opportunity to examine trajectories,
risk and protective factors, course, and consequences of a wide spectrum of abusive behaviors. The study will
undoubtedly inform the development of critically needed DV prevention and treatment programs.

Public health relevance
PROJECT NARRATIVE The long-term outcomes of and the factors that increase or decrease the likelihood of individuals experiencing dating violence are poorly understood. Most of our information comes from cross-sectional studies, which prevents us from knowing whether a particular variable precedes or follows dating violence. The current proposal will extend an ongoing study of dating violence, ultimately resulting in 15 years of (multi-informant) data on over 1,000 ethnically diverse participants and their current partners as they transition from adolescence to young adulthood.